RFA-CE-23-004 Experimental Evidence on the Effects of Academic Remediation on Violence

The pandemic has caused an increase in gun violence across the country, in rural and urban areas alike.
While the focus has been on immediate causes like the pandemic's effect on mental health, economic
conditions, other disruptions to social services, and the criminal justice system, much less attention has
been devoted to the potential long-term effects on gun violence and other forms of violence due to the
pandemic's effects on US education. Test score data show both the widespread prevalence and enormous
magnitude of learning losses for children at all ages all across the country. These massive learning losses
are concerning because of the strong correlation between education and violence (Lochner, 2020).
Through a partnership between the University of Chicago and the Chicago Public Schools (CPS), we seek
to produce evidence from randomized controlled trials (RCTs) about whether education causally reduces
violence, and whether public policy can avert the increases in violence we expect from pandemic-induced
learning loss at large scale. One of the most effective strategies for accelerating student learning is high-
dosage tutoring, or HDT, which bolsters test scores by 0.2 to 0.4 standard deviations (see Nickow et al.,
2020, Guryan et al., 2021).
We seek to use government administrative data to measure violence-related outcomes for two
retrospective RCTs of HDT carried out under ideal conditions in 2013-15 (like an efficacy trial), as well as
a prospective RCT of an even larger-scale implementation in CPS right now (more like an effectiveness
trial). The two retrospective RCTs enrolled 5,343 high school students, with test score gains of 0.18 and
0.40 SD (Guryan et al., 2021). While not the main focus of those RCTs, we did see suggestive indications
of potential violence-reducing effects. The prospective RCT tests the even larger-scale HDT CPS seeks to
deliver through its own in-house version of Saga tutoring, called CPS Tutor Corps, with 6,000 participants
expected.
We seek to link data on the retrospective and prospective RCT samples to data from several administrative
data sources on violence-related outcomes like arrests and victimizations, and overall ER visits. The two
retrospective (`efficacy') RCTs will let us measure impacts on violence involvement in both the short- and
longer runs and understand whether gains in educational achievement can reduce it; in the prospective
`effectiveness trial' of HDT, we will examine health outcomes in the short to learn of whether government
efforts to scale-up HDT can help reduce violence-exposure disparities due to education disparities. Finally,
we will focus on the mechanisms driving the impact on violence. We seek funding to complete the
realization of the ongoing RCT in Chicago and to support the efforts of obtaining access to the relevant
data on violence-related outcomes and linking it to the two studies.

Public health relevance
COVID-19 may have long-term effects on violence through an under-appreciated channel: learning loss for children in school, particularly to low-income and minority children, leading the U.S. Secretary of Education to recommend that schools leverage high dosage tutoring - a scalable and reliable policy to increase learning - to address the problem. As previous research has shown a strong positive correlation between education and violence but evidence for actionable educational policies is scarce, we aim to tackle the basic science question of whether education affects violence involvement, as well as the policy question of whether academic remediation can prevent the expected long-term increase in violent crimes and victimization. Our University of Chicago research team in partnership with Chicago Public Schools aims to use several randomized control trials (RCTs) delivering high-dosage tutoring interventions, two of which were carried out in 2013-15 under ideal field conditions and an additional larger-scale trial that is currently underway, linked to administrative longitudinal data on violence-related outcomes (offending and victimization) to produce short- and longer-term experimental evidence of the violence-reducing effects of tutoring delivered at different scales to answer our research questions.